An oxysterol drug candidate, Oxy210, for inhibition of pulmonary fibrosis through targeting hedgehog and TGFβ signaling

ABSTRACT
Idiopathic Pulmonary Fibrosis (IPF) is a chronic interstitial lung disease, characterized by progressive,
irreversible scarring of lung tissue and declining lung function, terminating in respiratory failure. Median patient
survival is limited to 3-5 years post diagnosis. Two currently available therapies, Pirfenidone and Nintedanib,
only slow the progression of the disease and have not greatly reduced IPF mortality or significantly improved
quality of life in IPF patients since they were approved in 2014. Hence, new and improved IPF drug candidates
are urgently needed. IPF disease progression is driven in significant part through inappropriate reactivation of
embryonic cellular signaling pathways, such as the Transforming Growth Factor beta (TGFβ) and Hedgehog
(Hh) signaling pathways. In fact, Pirfenidone and Nintedanib act in part through modestly blocking these signaling
pathways. At MAX BioPharma, we are developing novel, proprietary, oxysterol-based antagonists of aberrant
cellular signaling that may have disease modifying properties in human IPF and other fibrotic diseases. This
application covers an oxysterol-based drug candidate, Oxy210, a dual inhibitor of Hh and TGFβ signaling that
ameliorates hepatic fibrosis and inflammation in a humanized mouse model of non-steatohepatitis (NASH). In
this application, we present encouraging preliminary data from in vitro studies with Oxy210, demonstrating its
inhibitory effects on proliferation and pro-fibrotic gene expression in a normal pulmonary fibroblast cell line (IMR-
90) and an IPF patient-derived cell line (LL97A). Oxy210 has anti-inflammatory effects in LPS-treated
macrophages through direct inhibition of Toll-Like Receptor (TLR4), TLR2, and AP-1, and does not interfere with
the anti-inflammatory effects of TGFβ. Preliminary findings show the promising potential of Oxy210 to inhibit
bleomycin-induced pulmonary pathology in vivo in mice. We propose to further characterize Oxy210 in relevant
in vitro and in vivo models of IPF. Specifically, we propose to address the following specific aims: Aim 1.
Elucidation of the effects of Oxy210 on myofibroblast differentiation and activation of primary pulmonary
fibroblasts from normal lungs and from IPF patients in vitro. Aim 2. Identification of the effects of Oxy210 on
lung fibrosis, fibroblast activation, and macrophage phenotypes at different stages of disease progression using
RNA sequencing in bleomycin-treated mice. Aim3. Examination of Oxy210 safety using in vitro Ames,
Cytochrome P450 inhibition, and off-target activity studies. We anticipate that data from the proposed studies
will evaluate the potential of Oxy210 as a drug candidate for further development and targeting of IPF. Compared
to existing therapies, Oxy210 may be more effective and safer as a standalone therapy or when used in
combination with existing therapies for treating IPF.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The proposed studies will facilitate the therapeutic development of a novel class of oxysterol molecules that have been found to inhibit proliferation and pro-fibrotic gene expression in human pulmonary fibroblasts, and pulmonary fibrosis in a mouse model of pulmonary fibrosis. A lead compound, Oxy210, is a promising drug candidate that may be useful for intervention in pulmonary fibrosis. In proposed studies in this application, we will provide further support for the candidacy of Oxy210 for development into a potentially potent orally available anti-fibrosis compound.